SilverBills: A Financial and Legal Tech Tool for Caregivers

ABSTRACT
Financial and legal management for persons with dementia (PwD) is a crucial responsibility of caregivers. This
responsibility adds to the stress and strain of caregiving. Current technology tools that help with bill management
and budgeting often require a high degree of technical expertise and provide an insufficient degree of personal
support to address the caregivers' needs. Current approaches to financial management are typically aimed at
technologically savy millennials rather than caregivers. Additionally, these approaches do not address the need
for safe and accessible storage of legal documents. Thus, the current solutions available for these tasks are a
mismatch for caregivers. We will address the lack of effective financial management and legal support for
caregivers of PwD by building features on our existing SilverBills (V1) product that simplify financial
management, provide a supportive communication tool and a vault for critical legal documents. Using proprietary
technology, SilverBills receives, scrutinizes, stores, and pays bills on behalf of clients. SilverBills intends to use
this NIH grant to further develop its technology and tailor capabilities to specifically address the needs of
caregivers. The goal of this project is to decrease the stress and strain on caregivers of PwD, by providing a
simple, safe and effective financial and legal management tool. The objective of this Direct to Phase II SBIR
proposal is to develop an application designed for caregivers to oversee the financial activities of PwD and
quantitatively measure financial, emotional and physical wellbeing of caregivers. Our central hypothesis is that
use of the proposed Silverbills V2 product will improve overall wellbeing in caregivers of PwD. We aim to build
an easy to use, customizable, client facing application for caregivers to direct the financial activities of PwD. In
addition, we will enhance the capabilities of the application to reconcile banking information, detect fraud, secure
data, provide enhanced reporting capabilities and provide further budgeting and planning functionality. Finally,
in collaboration with researchers from the University of Denver, we will assess caregiver burden and physical,
financial, and emotional distress. The team supporting Silverbills V2 includes expertise in elder law, business
development, Ruby on Rails software engineering, financial security and cognitive health, caregiving, research
design and statistics. The work proposed in the Aims outlined above should demonstrate that the SilverBills V2
product will: 1) Provide a financial management tool which includes a messaging system and vault of critical
documents for caregivers of PwD and/or older adults, and 2) Evaluate the effectiveness of our product to
decrease caregiver stress and increase caregiver quality of life. This team will support the rigorous scientific
validation which will potentially provide evidence of our innovation and support this critical work to provide
technological tools for financial and legal management to caregivers of PwD.

Public health relevance
NARRATIVE Caregivers often bear the responsibility of managing financial and legal issues of persons with dementia. Unfortunately, caregivers are often unprepared and untrained for these crucial tasks, adding to their strain and stress. The goal of this project is to improve wellbeing for caregivers of persons with dementia through our Financial and Legal management tool.